Cooperative Agreement to Support the Western Center for Food Safety

Project Summary/Abstract
The primary goal of this 5-year project is to renew a cooperative agreement for the continued
support of the Western Center for Food Safety (WCFS). The WCFS functions as a dynamic
collaborative partnership between FDA and the University of California, Davis, and also as one
of four academic Centers of Excellence that support the mission-critical food safety and public
health goals promoted by FDA. The long-term goals of the WCFS are five-fold: (1) conduct
multidisciplinary applied laboratory, field, and educational research regarding the safety of
agriculture production to generate practical solutions that can be implemented by the
agricultural community and consequently, enhance food safety for FDA-regulated products; (2)
develop and maintain communication with various stakeholders, domestic and international,
involved in food production and food safety in order to identify food safety knowledge gaps and
opportunities to leverage resources; (3) enhance technical assistance, community outreach and
educational efforts through various venues, such as agricultural industry seminars,
presentations, serving on technical advisory boards and industry or regulatory committees,
publishing lay and scientific publications, and providing food safety education through local
agriculture extension offices; (4) engage in multi-institutional research collaborations to ensure
that FDA has the most current, scientific thinking on best agricultural practices across varying
agro-ecological landscapes; and (5) assist FDA in implementing the Food Safety Modernization
Act standards associated with the produce safety and preventive controls regulation.

Public health relevance
Project Narrative The primary goal of this cooperative agreement proposal is to continue the comprehensive food safety partnership between the Food and Drug Administration (FDA) and the Western Center for Food Safety (WCFS) at UC Davis. Similar to the past 15 years, WCFS will partner with FDA on conducting joint collaborative research projects, provide extension and technical assistance to agricultural communities, and assist FDA in implementing the Food Safety Modernization Act standards associated with the produce safety and preventive controls regulation. As a result of these efforts, the risk of foodborne microbial contamination of produce for the U.S. consumer will be reduced, thereby improving public health and the safety of the nation's food supply.